Yale Cancer Center NCTN LAPS

SUMMARY
Yale Cancer Center’s continuing participation in the NCTN under the leadership of Dr. Anne Chiang includes
not only a solid history of strong and committed accrual to NCTN trials, but strong leadership in the trial’s
efforts at SWOG and other groups. YCC remains committed to prioritizing NCTN trials at all the YCC clinical
centers and demonstrates annual accrual beyond estimates developed in our current U10 award. For this
current submission, the vision of the YCC leadership is to: 1) continue to prioritize NCTN trials for accrual and
develop YCC as a major contributor to group trials with additional contribution of our Care Centers; 2) facilitate
and encourage YCC faculty to assume leadership roles in SWOG and other NCTN groups by supporting their
time and effort and rewarding these activities; and 3) leverage our NCTN Coordinating Committee (NCC) as a
bridge to bring Yale translational science to group activities as the results of our investigator initiated pilot trials
become promising for multi-center and randomized questions. In addition to the leadership efforts of Dr.
Chiang, other key SWOG leaders include Drs. Roy Herbst, Daniel Petrylak and Lajos Pusztai. Drs. Peter
Glazer and Alessandro Santin will lead our efforts in the NRG group in addition to Dr. Barbara Burtness who
will continue to lead our efforts in the ECOG-ACRIN group. We believe that the science and translational work
at YCC has strong potential for incorporation into NCTN programs. Continued work on early phase drug
development, EGFR resistance, PD-1 signaling, chemical biology, and new targets in signal transduction
through the scientific programs of YCC have strong potential for translation into group trials. Furthermore, with
expansion of the Smilow Cancer Hospital Care Centers, we demonstrated a greater opportunity to bring NCTN
trials to the greater patient population across the state of Connecticut. This UG1 grant will assist us in
developing the appropriate leadership and infrastructure for support of key NCTN group efforts in both accrual
and program development.

Public health relevance
NARRATIVE As a LAPS, Yale University will continue its major contributions to the NCI supported National Clinical Trials Cooperative Group Program that has led and will continue to lead to new treatments for cancer patients while at the same time promoting efficiency and facilitating the prioritization of clinical research at the national level.